Intracranial arterial compliance, cerebral blood flow, and dementia risk in older adults with type 2 diabetes

Type 2 diabetes mellitus (T2DM), which is rising in prevalence, increases risk of cognitive impairment and
dementia, including Alzheimer's disease (AD). In our prior work we have shown that T2DM is associated with
steeper cognitive decline and reduced cerebral blood flow (CBF) in regions that are predilection sites for AD
pathology (Bangen et al., 2018; Bangen et al., in prep). Identifying individuals who are most likely to decline
prior to the occurrence of significant brain changes is essential so that interventions can be applied before
extensive cerebrovascular lesions and cognitive changes develop. Studies investigating incipient cognitive and
brain changes prior to the development of dementia are critical to optimize brain health and improve outcomes.
Most previous neuroimaging studies of brain changes underlying cognitive dysfunction in T2DM have
applied conventional structural magnetic resonance imaging (MRI) to detect end-stage macrostructural
changes associated with cerebrovascular disease (CVD) such as white matter lesions (WML). However, recent
advances in MRI have allowed for the development of sensitive methods for the non-invasive measurement of
CBF and cerebral arterial compliance (AC), or the ability of vessels to distend or increase in volume in
response to changes in blood pressure. Such methods may help elucidate mechanisms that precede the
development of irreversible parenchymal/structural damage and may yield important markers of risk for
cognitive decline. Although T2DM has been associated with peripheral arterial stiffening using carotid-femoral
pulse wave velocity, no studies have examined intracranial arterial stiffening (i.e., decreased AC) in T2DM.
We therefore propose to advance the field by longitudinally assessing neuropsychological functioning, AC
and CBF, and established MRI markers CVD in a sample of 150 older adults (aged 65-85) including 100 with
T2DM and 50 non-diabetic control participants. Participants will undergo comprehensive neuropsychological
assessment; laboratory testing to assess blood-based markers related to glycemia and cardiometabolic health;
and neuroimaging exams including high resolution structural imaging and novel arterial spin labeling (ASL)
MRI protocols that estimate cerebral arterial compliance and blood flow at baseline, 12-month follow up, and
24-month follow up. Our goals are to investigate whether early changes in cerebrovascular functioning (i.e.,
reduced AC and CBF) relate to MRI markers of CVD lesions and cognition in T2DM. We will also investigate
whether diabetes related factors (e.g., duration, glycemic control) and comorbid cardiometabolic conditions
(e.g., hypertension) moderate associations between AC, CBF, CVD markers, and cognition. Findings will help
address an important public health need by identifying markers of cognitive decline in T2DM and elucidating
potentially modifiable mechanisms underlying these changes. Results may also assist in facilitating targeted
interventions given that presence of cognitive dysfunction may affect both dosing and broader management of
individuals with T2DM.

Public health relevance
Diabetes increases the risk of cognitive impairment and dementia although the underlying mechanisms remain incompletely understood. We aim to evaluate newly developed, noninvasive measures of cerebral arterial compliance and blood flow in order to determine whether early functional brain changes proceed the development of irreversible cerebrovascular lesions and cognitive decline in older adults with diabetes and non-diabetic control participants. We will also examine the role of treatable/potentially modifiable mechanisms underlying cognitive changes, with the ultimate goals of advancing our understanding of the pathogenesis of diabetes-related cognitive dysfunction and identifying individuals at risk for cognitive impairment so that interventions to reduce dementia risk can be started as early as possible in order to improve health and functioning.